Elucidating the role of transcriptomics in driving ethnicity and ancestry-related disparities in colorectal cancer

ABSTRACT
The benefits of precision oncology advances in colorectal cancer (CRC) have not been shared by all individuals.
Prognosis among minority groups remains stubbornly low in comparison to non-Hispanic White (NHW)
individuals. Immunotherapy has arguably been the most important advance in treatment for CRC in this past
decade. This is particularly relevant for microsatellite instable tumors that harbor high mutational and neoantigen
burden, where immune checkpoint inhibitors (ICIs) are highly effective and FDA-approved. However, despite
dramatic activity in some CRC patients (including evidence that African American (AA) patients may exhibit better
responses to ICIs), a much larger fraction of patients do not respond. As a result, extensive efforts to understand
and manipulate the tumor immune microenvironment features that influence response to ICIs and other targeted
therapies are ongoing and forthcoming. Also needed are studies to identify unique molecular targets for
developing new precision medicine interventions. An underexplored molecular mechanism with potential to
advance the fields of immune-oncology and targeted therapy is RNA splicing, a key step in gene expression that
generates multiple ‘alternative’ mRNA transcripts, encoding functionally distinct protein isoforms that expands
the functional repertoire of the genome. When dysregulated, in cancer, RNA splicing can result in pathogenic
variants and immunogenic neoantigens. When neoantigens are present in high abundance, ICIs are most
effective. The significance of RNA splicing in CRC is supported by a study demonstrating that splice neoantigens
enhanced ICI blockade in a mouse model and studies showing that pathogenic RNA splice variants can drive
every hallmark of cancer, with potential to be therapeutically targeted. Mounting evidence demonstrates that
RNA splicing events are influenced by genetic ancestry and are important in CRC, including our recent work
identifying race- and ancestry-related RNA splicing associated with cancer biology, therapeutic response and
survival. Our goal is to understand the contribution of RNA splicing events to disparities in treatment response
and outcomes in CRC. Quantifying how race, ethnicity and ancestry influence the transcriptome and outcomes
will generate much-needed knowledge in CRC disparities. Our proposal leverages existing diverse cohorts with
biospecimens and annotated data including the Latino Colorectal Cancer Consortium (LC3), the Detroit
Research on Cancer Survivors (ROCS), and The Cancer Genome Atlas (TCGA). We will address three aims:
(1) characterize expression patterns of alternative mRNAs and genes encoding splicing factors by genetic
ancestry and across self-reported racial and ethnic groups (250 AA, 250 Hispanic/Latino and 250 NHW patients);
(2) examine the role of RNA splicing in tumor-associated immune responses; and (3) determine the functional
consequences of expression of prioritized RNA splice variants with respect to CRC biology in vitro and in vivo
(using CRISPR/Cas9 genome edited CRC cell lines). This project will be the first of its kind to relate alternative
mRNA species, neoantigens, and CRC outcomes considering the influence of genetic ancestry.

Public health relevance
NARRATIVE Immunotherapy and targeted therapy have arguably been the most important recent advances in treatment for colorectal cancer (CRC), but such advances have not equally benefited all individuals. Our goal is to identify and characterize the underexplored, critically important molecular mechanism of RNA splicing in CRC among patients of different races, ethnicities and ancestries and its influence on outcomes and disparities across these populations. To do this, we will use preclinical CRC models and leverage existing diverse cohorts with biospecimens and annotated data including the Latino Colorectal Cancer Consortium (LC3), the Detroit Research on Cancer Survivors (ROCS), and The Cancer Genome Atlas (TCGA).